Unraveling Molecular Mechanisms Underlying Heroin-induced Mitochondrial Perturbations

Project Summary/Abstract
The opioid epidemic has continued to be a major public health issue within the United States,
contributing to ~100,000 overdose deaths. Opioid abuse contributes to more than just the more often
focused addiction related behaviors. Long-term heroin exposure has recently been linked to the
acceleration of neurodegenerative disease-like changes. Utilizing bulk RNA sequencing, we measured
the gene expression signature within the dorsal striatum in human heroin users and aged matched
controls. In addition to replicating previous findings relevant to behaviors related to the effects of
opioids, we also identified a large set of genes that were altered related to mitochondrial oxidative
phosphorylation and the electron transport chain. These genes, which were predominantly
downregulated, were also enriched in KEGG ontology pathways related to several neurodegenerative
diseases such as Alzheimer’s, Parkinson’s, and Huntington’s. My project aims to investigate the casual
role heroin self-administration has on the mitochondrial transcriptional profile in the rodent dorsal
striatum following heroin exposure using RNA sequencing. Additionally, I will use in-vivo and in-vitro
models to elucidate the impact of opioid exposure on mitochondrial morphology and function. To that
end, I will leverage immunohistochemistry to visualize perturbations on the mitochondrial network and
use Seahorse assay to measure changes in oxygen consumption rate of mitochondria in cells to assess
ATP production efficiency. Lastly, leveraging immunohistochemistry and functional strategies used in my
cell culture and rodent model, I will assess mitochondria characteristics in post-mortem dorsal striatum
tissue of heroin users. Altogether, this project will allow me to gain significant training in bioinformatics,
RNA sequencing, metabolic assays, immunohistochemistry, and behavioral assays that will provide a
significant foundation for my future development as an independent researcher to answer questions
that might start from studies of the human brain to subsequently interrogate underlying neurobiological
mechanisms and behavior in translational models.

Public health relevance
Project Narrative: Opioid use disorder continues to be a major public health crisis affecting nearly 2.1 million people in the United States with broad impact. The complex molecular changes following heroin abuse remain understudied. My project aims to investigate heroin-induced changes of mitochondrial biology and metabolism in the brain relevant to neurodegenerative processes.